Manipulating Lipid Metabolism to Reverse Immune Dysfunction in Solid Cancers

PROJECT SUMMARY
The solid tumor microenvironment (TME) imprints a compromised metabolic state in which tumor infiltrating
lymphocytes (TILs) are unable to maintain effective energy synthesis for antitumor function and survival. CD8+
T cells in the TME must catabolize lipids via mitochondrial fatty acid oxidation (FAO) to supply energy in nutrient
stress, with T cells enriched in FAO being adept at cancer control. However, endogenous CD8+ TILs and
unmodified cellular therapy products fail to sustain bioenergetics in tumors, and the direct molecular mechanism
that underlies this failure is unknown. Discovery of a molecular target that enables TILs to utilize effective
antitumor metabolism could be implemented immediately to improve clinical immunotherapies. Using RNA-
sequencing, lipidomics, confocal imaging, and spectral flow cytometry, we identified that abnormal lipid
accumulation was associated with CD8+ TIL metabolic failure across multiple solid tumor types. Acetyl-CoA
carboxylase (ACC) is an enzymatic switch that drives lipid accumulation in nutrient-replete states. Under nutrient
limitation, ACC is inhibited to enable lipid catabolism through mitochondrial FAO. Paradoxically, we observed
that the TME imposes perpetual ACC activity in CD8+ TILs, enforcing lipid storage that directly opposes FAO.
Moreover, elevated ACC1 gene expression in tumor samples from melanoma and sarcoma patients was
associated with poor survival outcomes. Strikingly, we found that restricting ACC wholly rewired T cell lipid
utilization and metabolism, producing a T cell pool enriched in mono and polyunsaturated fatty acids that could
be rapidly metabolized for energy, supporting T cell control tumor control. This research program will use genetic
mouse models, tumor tissue from cancer patients with advanced disease, pre-clinical CAR-T cell mouse models,
and CAR-T products infused into cancer patients to formally test that ACC is a crucial enzymatic switch that
profoundly limits antitumor immunity, restricting cancer control. Aim 1 of this proposal will use WT littermate and
CD8creACC1f/f mice paired with tumor growth studies, lipidomics, metabolomics, and free fatty acid (FFA)
analysis to test that the solid TME engages ACC1 to induce steatosis and loss of antitumor function in
endogenous CD8+ TILs. We will validate the clinical relevance of our hypothesis using primary tissue from cancer
patients and stored samples from metastatic melanoma patients treated with PD-1 inhibitors. Aim 2 of this
proposal will use pre-clinical human and immune-competent CAR-T cell models paired with lipidomics,
metabolomics, FFA analysis, and tumor growth studies to test that limiting ACC optimizes CAR-T cell
performance in solid tumors. We will validate the clinical relevance of our hypothesis using CAR-T cell products
previously infused into cancer patients. Results generated from this proposal will formally establish that the solid
TME enforces ACC expression in CD8+ TILs, undermining bioenergetic plasticity by enforcing lipid storage. The
data will fill a long-standing gap in knowledge surrounding T cell metabolism in tumors, providing a revolutionary
molecular switch able to enhance endogenous and cell-based immunotherapeutic potency.

Public health relevance
PROJECT NARRATIVE The solid tumor microenvironment imprints a compromised metabolic state in which tumor infiltrating lymphocytes (TILs) are unable to maintain energy synthesis for function and survival. Here, we have identified a molecular switch that enables TILs to utilize lipids for energy in solid tumors which can be employed clinically to improve multiple immunotherapies. This research program will formally prove that steatosis profoundly limits antitumor immunity, restricting cancer control.